Children's Oncology Group

PROJECT SUMMARY
Since the introduction of combination chemotherapy for the treatment of childhood leukemia more than 60
years ago, the prognosis of childhood cancer has improved dramatically. The 5-year survival rate for childhood
cancers, many of which were uniformly fatal in the pre-chemotherapy era, is now over 85% for all forms of
childhood cancer combined. Progress for several childhood cancers, however, has been limited, with
approximately 50% of children with acute myelogenous leukemia, 50% of children with high-risk
neuroblastoma, and more than 90% of children with brainstem glioma, still succumbing to their disease. In the
US, cancer remains the leading cause of death from disease in children greater than one year of age.
Moreover, the late effects of cancer treatment, including permanent organ and tissue damage, hormonal and
reproductive dysfunction and second cancers, are of special concern, with more than 40% of the 500,000
survivors of childhood cancer (estimated as of 2020) experiencing a significant health related quality of life
complication from childhood cancer and its treatment. Thus, despite our advances, development of new
therapeutic approaches must be a priority for childhood cancer basic, translational and clinical researchers.
Children’s Oncology Group (COG), the world’s largest organization devoted exclusively to childhood and
adolescent cancer research, was founded 25 years ago. COG’s multidisciplinary research team, comprised of
more than 13,000 members, conducts research at more than 220 leading children’s hospitals, universities, and
cancer centers. This proposal is for COG, as part of the National Cancer Institute’s (NCI) National Clinical
Trials Network (NCTN), to continue its collaborative research work that supports the mission of improving the
outcome for all children with cancer. COG will design and conduct clinical-translational studies for children with
cancer that builds on an increasing understanding of the molecular basis for pediatric malignancies and has
the highest potential to improve the outcome. Using innovative clinical trial designs suitable for the study of
rare diseases, we will study novel therapeutic approaches including but not limited to targeted small molecule
drugs, immunotherapies and cellular therapies. The COG research portfolio importantly also includes clinical
trials focused on improving the quality of life for children with cancer and childhood cancer survivors. Since
approximately 80% of children diagnosed with cancer in the US are treated at COG member institutions, COG
can offer a diverse population of children with cancer and their families the opportunity to participate in
innovative research. This research effort includes allowing for collection and annotation of biospecimens from
all children with cancer, providing the foundation for discovery and accelerating the most promising research
efforts conducted in laboratories around the world. The proposal is for support of the COG Statistics and Data
Management Center to collaborate with COG scientific leaders to design, conduct, analyze and report the
results of clinical-translational trials for the treatment of childhood cancers.

Public health relevance
PROJECT NARRATIVE The Children’s Oncology Group (COG) is the world’s largest organization devoted exclusively to childhood and adolescent cancer research. Over 220 leading children’s hospitals, universities, and cancer centers across US, Canada and other countries participate in COG research, which is focused on developing better treatments that can improve the cure rate and outcomes for all children with cancer.